Mechanisms of Dietary Nutrient Absorption

ABSTRACT
Our long-term objective is to define mechanism that regulate lipid flux in cells and animals and to elucidate
their impact on metabolic disease. Crosstalk with resident immune cells of the lamina propria of the gut has
been shown to influence the function of the absorptive epithelium, but molecular mechanisms whereby cellular
lipid levels in immune cells regulate this communication are largely undefined. We have discovered that
accessible PM cholesterol abundance in gut T cells is a potent modulator of dietary lipid absorption. Our
preliminary data show that inactivation of Aster-A induces changes in TH17 cell signaling, including production
of the cytokine IL-22, that alter systemic metabolism and energy balance. Here we propose a complementary
series of cellular, animal and pharmacological studies to define the underlying molecular mechanisms and
physiological implications of this discovery. Specific Aim 1 is to understand the mechanism(s) whereby gut T
cells modulate dietary lipid absorption. We will define signaling components that mediate the suppression of
fatty acid uptake by IL-22, taking advantage of genetic models, chemical inhibitors and intestinal enteroids.
Specific Aim 2 is to elucidate the role of IL-22/IL-22R signaling in intestinal and systemic lipid homeostasis.
We will further define the importance of the IL-22/IL-22R axis for whole-body physiology and energy balance.
We will utilize a novel AlpiCreER; Il22ra1F/F mouse model to dissect the function of the IL-22/IL-22R axis
specifically in mature enterocytes. Specific Aim 3 is to define intrinsic and environmental cues that regulate
fatty acid absorption. Diet composition has long been known to impact systemic metabolism. We hypothesize
that environmental factors that perturb IL-22/IL-22R axis may serve to modulate intestinal metabolism. We will
now examine the effects of dietary AHR ligands such as indole-3-acetate and tryptamine that are produced by
gut microflora from ingested tryptophan. To define specific gut immune cell populations responsive to these
environmental cues, we will delete IL-22 in T cells or type-3 innate lymphoid cells and characterize their
function importance in intestinal metabolic responses including the response to AHR agonists.

Public health relevance
Project Narrative We have discovered that lipid metabolism in lymphocytes that reside in the gut regulates the amount of lipid that can be absorbed from the diet. We will investigate the function and mechanism of action of the cytokine IL-22 in limiting intestinal lipid absorption and its ability to affect whole-body metabolism. Our analysis will shed light on the physiological role of immune signaling in enterocytes and may highlight opportunities for treating malabsorption or hyperlipidemia and obesity disorders caused by mucosal immune imbalances.